Rheumatology Research Training Program

PROJECT SUMMARY
This proposal is a new submission of a National Research Service Award for Rheumatology Research Training
at Northwestern University Feinberg School of Medicine. The overall objective of this training program is to
produce a diverse pool of well-trained scientists with the skills necessary to conduct rigorous and reproducible
research in the causes, treatment, and prevention of arthritis, musculoskeletal, and autoimmune diseases. This
application comes at a time of substantial and sustained growth in the research enterprise of Feinberg School
of Medicine, including within the Division of Rheumatology. This application requests three postdoctoral
training positions per year. The training program will be led by Drs. Yvonne Lee and Harris Perlman, who have
complementary expertise that spans from clinical medicine to basic science. Drs. Lee and Perlman will be
supported by an Internal Advisory Committee and an External Advisory Committee, who will assist in
overseeing and monitoring the program to ensure appropriate and timely trainee progress. Trainees will be
supported by a mentoring team, including at least one primary research mentor, one secondary mentor, and
one data science mentor. The research mentors will be drawn from a diverse pool of 23 well-funded principal
investigators, which include faculty from a variety of scientific backgrounds and disciplines, all with a common
goal of improving the outcomes of individuals with arthritis and autoimmune diseases. Didactic opportunities
include obtaining a Master of Science in Clinical Investigation through Northwestern University’s CTSA-funded,
part-time graduate program, which focuses on producing clinical scientists knowledgeable about the complex
issues associated with conducting sound, translational and clinical, patient-oriented studies. In addition, our
program is attuned to challenges related to recruiting and retaining individuals in scientific careers and will
provide a wellness program that assists in work-life balance, financial stability, relationship openness, and
future planning. The training program will be supported by a rich and diverse scientific environment, which
includes the FIRST-DailyLife Core Center for Clinical Research (NIAMS-funded P30) and the Northwestern
University Clinical and Translational Sciences Institute (NIH-funded CTSA). Specific research priority areas
include: a) development of organoid models, b) genetic murine models, c) precision medicine in human
disease, d) mechanistic/physiologic research, e) outcomes/interventional research, and f) epidemiology/health
services research. Through this training program, we expect to nurture bright, well-trained, academically-
oriented postdoctoral trainees in their pursuit of a career in rheumatology investigation. By enabling them to
synthesize information about the complex issues associated with conducting scientifically and ethically sound
research, we will maximize the likelihood that they will be competitive in seeking independent research
support, ultimately exerting a sustained influence on the field of rheumatology research.

Public health relevance
PROJECT NARRATIVE The shortage of research trainees in rheumatology has reached crisis proportions in academic medicine and is an urgent unmet need. There is a critical need to train highly competent M.D. and Ph.D. investigators to conduct patient-centered research leading to improved care for patients with rheumatic disease. The goal of the Northwestern University Rheumatology Research Training Program is to nurture motivated, bright, enthusiastic, well-trained, academically-oriented M.D. and Ph.D. investigators in their pursuit of careers in Rheumatology research.